Role of the parasubthalamic nucleus (PSTN) in the central regulation of feeding behavior

PROJECT SUMMARY
The motivation to eat depends on the relative balance of activity between orexigenic (appetite inducing)
and anorexigenic (appetite suppressing) brain systems. An abnormal balance of activity in these
systems can lead to substantial health problems with high associated economic costs. In the United
States, over half the population is considered overweight, and the aggregate economic cost is
estimated in excess of $60 billion per year. Undernourishment is also a substantial problem: abnormal
appetite suppression, as can occur during infection, old age, and cancer, can lead to severely low body
weight and malnutrition. However, despite obvious importance, the neural basis of hunger and appetite
suppression continues to be poorly understood at a neuronal or circuit level, and is currently an
important focus of investigation.
In recent years, the parasubthalamic nucleus (PSTN), a relatively understudied population of
neurons in the posterolateral hypothalamus, has been recognized as playing an important role in the
regulation of appetite suppression. However, several important questions about the PSTN remain. The
purpose of this proposal is to study the afferent connectivity, activity patterns, and necessity of
individual PSTN subpopulations in mediating appetite suppression. In Specific Aim 1, we will determine
the sources of incoming, afferent projections to individual PSTN subpopulations. In Specific Aim 2, we
will study whether orexigenic stimuli and anorexigenic stimuli have opposing effects on PSTN neuronal
activity. In Specific Aim 3, we will test the necessity of individual PSTN subpopulations for the appetite
suppression observed following a large meal and in response to appetite-suppressing hormones. We
will also study the necessity of PSTN neurons that project to specific, downstream targets in the brain in
mediating the effects of appetite-suppressing hormones. Taken together, the experiments in this
proposal will allow for continued understanding of the role of the PSTN in the central regulation of
feeding behavior.

Public health relevance
PROJECT NARRATIVE The purpose of this proposal is to investigate the role of a relatively unexplored population of neurons in the parasubthalamic nucleus (PSTN) in appetite suppression. We will determine the upstream neurons that project to the PSTN, determine the hormones that stimulate or inhibit the PSTN, and determine if the PSTN is necessary for appetite suppression in a variety of conditions. Our results will provide new insights into how the brain regulates food intake and potentially yield novel therapeutic targets for the re-establishment of hunger in conditions of extreme loss of appetite.